Interplay Between SERPINB1 and TLR2/TLR4 in Beta Cell Regeneration

SUMMARY
Pancreatic β cell regeneration is a promising approach for the treatment of insulin dependent type-1 (T1D) and
-2 diabetes (T2D). However, the nature of the signaling pathway(s) responsible for the age-dependent decline
of β cell proliferation remains an enigma, a significant roadblock in diabetes therapy. The Kulkarni laboratory at
Joslin Diabetes Center recently reported that SerpinB1 secreted from the liver promotes β cell proliferation (El
Ouaamari et al. Cell Metabolism 2016) while the Qi laboratory at the University of Michigan showed that Toll-
Like Receptors 2 and 4 (TLR2/TLR4) signaling pathways, two redundant innate immune signaling pathways,
block diet-induced β cell replication (Nat Immunol, under revision). In this application, the Kulkarni and Qi
laboratories will team up to test an overarching hypothesis that the antagonistic interplay between SerpinB1
and TLR2/TLR4 maintains a balance in favor of β cell regeneration in both mice and humans under
diabetogenic stimuli. We propose that TLR2/TLR4 activation in diet-induced obesity blocks SerpinB1-mediated
β cell replication while simultaneous disruption of TLR2/TLR4 signaling pathways on β cells may promote β cell
proliferation via SerpinB1-dependent manner. To this end, we will (i) perform lineage tracing to test the
hypothesis that TLR2/TLR4 regulates β cell replication in a β cell autonomous manner; (ii) delineate the
interplay between TLR2/TLR4 and SerpinB1 and the underlying mechanism in the regulation of β cell
regeneration; and (iii) determine the therapeutic potential of targeting TLR2/TLR4 and SerpinB1 in β cell
proliferation and regeneration using human β cells and islets. Hence, this study will be instrumental in
demonstrating that metabolic and innate immune systems, two primitive systems critical for the long-term
homeostasis of multi-cellular organisms, have evolved to promote cooperative, adaptive responses against
diverse environmental challenges such as overnutrition. If successful, this study will help realize therapeutic
potential of our discoveries and benefit millions of diabetic patients worldwide by delivering novel, invaluable
therapeutics for the treatment of widespread diabetes.
RELEVANCE TO HUMAN HEALTH: This application, with parallel mouse models and human islets studies,
will reveal novel molecular and cellular mechanisms, shaped by metabolic and innate immunity signaling
pathways, which govern β cell replication and metabolic homeostasis. Hence, this study may fundamentally
change our views of metabolic-innate immune interactions, and hold tremendous promise to uncover both
novel disease mechanisms and pharmacological targets aimed at treating and reversing the underlying
metabolic imbalances in diabetes.

Public health relevance
PROJECT NARRATIVE The nature of the signaling pathway(s) responsible for the age-dependent decline of β cell proliferation remains an enigma, a significant roadblock in diabetes therapy. In this application, the Kulkarni and Qi groups will work together to elucidate positive and negative signals regulating diet-induced β cell regeneration in adults and determine the therapeutic potential of targeting these signaling pathways in humans. !